Supplement to Biophysical Study of Reconstituted Kinetochore-microtubule Attachments

PROJECT SUMMARY The goal of this equipment request is to acquire a new ultracentrifuge instrument and a pair of new Ti45 ultracentrifuge rotors. These items will enable purification of large quantities of tubulin protein with far greater efficiency than has been possible using the borrowed and aging equipment on which we currently rely. Purified tubulin is a fundamental resource required for all of our biophysical studies of the mitotic spindle machinery. Purified tubulin is also required for our collaborations with several local NIH‐funded laboratories.

Public health relevance
PROJECT NARRATIVE During cell division, duplicated chromosomes are organized and separated by an exquisite molecular machine, the mitotic spindle. This project will bring us closer to a complete understanding of how the spindle works. Having a mechanistic understanding of the spindle promises to revolutionize the design of chemotherapeutic drugs that target spindle components. Ultimately, it may also guide efforts to develop useful human‐made nanomachines, which thus far cannot match the remarkable abilities of naturally occurring protein machines.